Functional genomics of GxE in cardiovascular disease: BPA, phthalates and their interactions with gene regulation

Abstract
Cardiovascular disease is the leading global cause of death, accounting for more than 17.9 million deaths
per year in 2015, a number that is expected to grow to more than 23.6 million by 2030. Several genetic and
environmental factors contribute to cardiovascular disease risk. Bisphenol A and phthalates are two endocrine
disruptors that are widely present in plastic and cosmetic products of daily use. These chemicals induce endothe-
lial cell death and have been associated with increased risk for atherosclerosis and coronary artery disease. We
propose to identify genetic variants that interact with BPA and phthalates and modify gene regulation in vascular
cells, with consequences for cardiovascular health. We will use RNA-seq and ATAC-seq to characterize gene
expression and chromatin accessibility changes induced by BPA and phthalates in vascular cells. We will focus
on vascular endothelial and smooth muscle cells from African American donors, a population group at a higher
risk of dying of preventable cardiovascular disease, compared to European Americans, but underrepresented in
genetics and functional genomic studies. Using molecular QTL mapping approaches we will discover new gene-
environment interactions for BPA and phthalates. We will then use computational predictions and statistical
genetics approaches to ﬁne-map these gene-environment interaction signals and colocalize them with associ-
ation data for cardiovascular disease. Finally, we propose to use massively parallel reporter assays to validate
these GxE in gene expression and deliver a catalog of functionally validated GxE risk factors for cardiovascular
disease.

Public health relevance
Project Narrative Cardiovascular disease accounts for nearly 1 of every 3 deaths in the US, an average of 1 death every 38 seconds. The purpose of this project is to use functional genomic assays and novel statistical and computa- tional methods to identify common genetic factors that interact with BPA and phthalates exposure and provide a molecular mechanism for inter-individual variation in endothelial function and cardiovascular health.